Cellular and Molecular Mechanisms of Renal Anemia

Our studies advance knowledge about the cellular and molecular mechanisms that underlie the pathogenesis
of anemia associated with chronic kidney disease (CKD), also called renal anemia. CKD represents a major
public health burden worldwide and is associated with high cardiovascular morbidity and mortality. In the
United States the prevalence of CKD in the general population has been estimated to range between 10 and
15% and is even higher in veterans.
Anemia is a classic manifestation of advanced CKD and results from (erythropoietin) EPO deficiency and
dyregulated iron homeostasis. The current treatment of renal anemia consists of EPO replacement therapy
with recombinant versions of EPO, typically administered in conjunction with intravenous iron. Although
recombinant EPO is effective in treating renal anemia, clinical studies have raised significant concerns
regarding its cardiovascular safety profile, providing a strong incentive for the development of new therapeutic
approaches.
EPO deficiency results from the diminished ability of diseased kidneys to produce adequate amounts of the
glycoprotein hormone EPO in response to anemia or hypoxia. EPO is essential for red blood production and
is produced in the kidney by perivascular fibroblasts and pericytes. In these kidney interstitial cells, oxygen-
dependent prolyl 4-hydroxylase domain (PHD) dioxygenases (PHDs) function as the oxygen-sensors that
control EPO synthesis by regulating hypoxia-inducible factor (HIF) 2 activity. The inability to activate HIF2
leads to EPO deficiency as shown by our laboratory. Perivascular fibroblasts and pericytes give also rise to
myofibroblasts, which promote kidney fibrosis through the enhanced production of collagen and other matrix
molecules. Thus, kidney fibrosis and the development of EPO deficiency are directly linked.
Despite their importance in erythropoiesis and pathogenesis of kidney fibrosis, very little is known about the
metabolic characteristics of renal interstitial cells. In particular, the role of mitochondria in interstitial cell
differentiation and function is unclear and has not been investigated.
Under this grant, we hypothesize that mitochondria play a central role in the regulation of renal interstitial cell
differentiation, HIF2 oxygen sensing and pathogenesis of EPO deficiency in CKD. The application uses
genetic mouse models in conjunction with state-of-the-art high resolution 3D imaging of mitochondria,
metabolic flux analysis and single cell transcriptomics to investigate a) the role of mitochondrial depletion in
renal interstitial cell differentiation and metabolism, b) the role of mitochondria in the regulation of the
HIF2/PHD/EPO axis and hypoxia responses in renal interstitial cells, and c) the role of the mitochondrial
electron transport chain in the development of EPO deficiency and renal anemia.

Public health relevance
Advanced chronic kidney disease represents a major cause of morbidity and mortality for our Veterans and is frequently associated with anemia, the inability of the body to produce adequate numbers of red blood cells. This grant investigates the role of mitochondria in the regulation of erythropoietin, the hormone that is made by the kidney and is essential for red blood cell production. Work proposed under this grant will further our understanding of the metabolic causes of anemia associated with kidney failure. This project has potential for the development of novel therapeutic approaches for the management of anemia in patients with chronic kidney disease.